Global control of co-transcriptional splicing

Project Summary
Alternative splicing (AS) is a widespread phenomenon in human genes that significantly diversifies the types of
proteins and RNAs produced. This process plays an essential role in defining cellular differentiation and identity3,4.
Moreover, problems in alternative splicing have been directly linked to a range of human diseases such as
muscular dystrophies, neurodegenerative conditions, and cancers. The typical human gene has about eight
introns, which are processed by spliceosomal subunits that recognize sequences near splice sites (SSs) and
branchpoints. During the splicing process, AS arises as the result of kinetic competition between multiple
possible splicing outcomes that is influenced by cis-elements and trans-acting factors. Additionally, AS is
influenced by chromatin and transcription rates, as splicing is coupled with gene transcription. The splicing
process and its regulation are highly transient. Spliceosomal assembly is initiated by U1 snRNP binding to the
5’ SS and the branch point located upstream of the 3’SS is recognized by the U2 snRNP. Subunits of both U1
and U2 associate with Pol II co-transcriptionally prior to recognizing their respective cis-elements. Additionally,
regulatory factors that aid in splice site recognition and control splicing outcomes bind to specific sequences in
nascent RNA. Since these cis-elements are usually located within introns, their influence is temporary and lasts
only until the introns are removed. Thus, to understand AS requires quantitative in vivo analyses of the dynamics
of intron excision within the context of the native genomic context. Our group has pioneered tools that obtain
direct, high-resolution, and quantitative views into the endogenous splicing process, both during and after
transcription. These methods have revealed that splicing itself occurs far after RNA synthesis14 and that the order
of intron excision is largely fixed across cell types and controlled heavily by cis-elements in the nascent RNA13.
Here we propose to apply these tools to determine how trans-acting factors affect the relationship between
transcription and splicing and how cis-elements in nascent RNA impact splicing dynamics and outcome. We will
examine how regulators of splicing and transcription manage the intricate relationship between these two
processes. To examine how cis-elements control splicing order, we will investigate how natural variation of the
pre-mRNA sequence influence its processing. Additionally, we will use our unique RNA flow technique15 to
quantitatively track RNA molecules throughout their life cycle, from synthesis to degradation, giving us insights
into how these factors affect the RNA's ultimate fate. In specific aim 1, we will investigate mechanisms of factors
connecting splicing to transcription. In specific aim 2, we will study the role of cis-elements in determining splicing
order. Overall, our multi-faceted approach aims to provide a comprehensive understanding of the mechanisms
that regulate RNA processing, offering critical insights that could inform future research and therapeutic
strategies.

Public health relevance
Project Narrative The proposed research is relevant to public health, because dysregulated alternative splicing leads to a broad range of diseases, including many cancers and neurological disorders. Our proposed research will shed light on how splicing is regulated, which could reveal novel therapeutic strategies to rescue disease-causing splicing defects. As such, the proposed research is relevant to the part of the NIH’s mission that seeks to develop fundamental knowledge to inform our diagnosis and treatment of human disease.